Intrasurgical tissue engineering of autologous grafts using irreversible electroporation for bladder reconstruction

PROJECT SUMMARY
Bladder reconstruction (BR) is essential to restore urinary function in patients with neurogenic bladder,
congenital disorders, and as sequalae to the surgical treatment of bladder or pelvic malignancies. The current
standard of care is to use the patient's own intestinal tissue (ileal segment; IS) as graft material during BR to
create a neobladder or urinary diversion. While IS grafts are non-immunogenic and readily available, post-
surgical persistence of intestinal cells in the graft impedes regeneration into bladder wall, resulting in stone
formation, metabolic acidosis and risk of secondary cancers. Our objective is to develop new technology for
intrasurgical tissue engineering of the IS by knockdown of cellular components using irreversible
electroporation (IRE) and identify factors fundamental for regeneration of functional bladder wall. IRE is used in
patients for tumor ablation by inducing cell death with ultrashort electric pulses. Our proposed strategy builds
upon our preliminary data showing (i) IRE can knockdown intestinal cells in an IS graft, aiding repopulation
with urothelium in a rat model of BR, (ii) feasibility of new pulse application strategies for the focal knockdown
of mucosa, or decellularization while preserving vasculature and ECM in the IS, and (iii) phenotypic changes in
IRE treated IS following urothelialization, that were not observed in sham controls under physiologic conditions
of bladder filling and voiding. In specific aim 1, we will Define the impact of graft perfusion on bladder wall
regeneration by performing vasculature sparing IRE of the IS. In specific aim 2, Elucidate the role of IS
mucosa in post-BR complications by knockdown with IRE. In specific aim 3, Investigate the role of
mechanotransduction in bladder function development in IRE treated IS. Intrasurgical creation of a perfused,
histocompatible graft (Aim 1) and focal decellularization of the mucosa while sparing the underlying layers in
the IS (Aim 2) are the first examples of in vivo knockdown tissue engineering using IRE. The study and
application of mechanotransduction principles to augment urinary barrier function development in IS grafts
(Aim 3) is previously undescribed. Knowledge gained from proposed research will yield a simple intrasurgical
technique (mt-IRE or vs-IRE) that combines technology (IRE) and grafting technique (with IS) that are already
in the clinic, enabling rapid translation for the immediate benefit of patients undergoing BR. Eventually, we
anticipate our work to advance the concept of in vivo production of functionalized grafts using the patient as the
source of biomaterial and the bioreactor, with application to reconstructive surgery involving other tubular
organs such as the esophagus, trachea or large blood vessels.

Public health relevance
PROJECT NARRATIVE Patients undergo bladder reconstruction to improve or recover normal urinary function that has been impaired due to non-malignant conditions or as a consequence of surgical treatment of bladder cancer. Herein we propose the application of intrasurgical irreversible electroporation to decellularize an intestinal segment, engineering different types of tissue scaffolds that can aid bladder regeneration, further augmented by a biochemical agonist that can simulate the effects of mechanotransduction. The anticipated clinical impact is to improve the outcomes of reconstructive bladder surgery by reducing patient morbidity and through sustained increase in long-term bladder function, where the significance of our proposed work is underscored by the creation of new tools and techniques for tissue engineering and regenerative medicine.